A novel determinant of prostate cancer growth

Project Summary/Abstract
Prostate cancer (CaP) will cause the deaths of more than 33,000 American men in 2020 because systemic
treatments for metastatic CaP fail. Actionable targets for novel treatments that work via entirely different
mechanisms, bypass resistance to current therapies, and control biology that drives CaP progression are needed
urgently to improve patient survival. The long-term goal is to target the mechanism(s) that control CaP cell
proliferation and CaP growth for therapeutic intervention. Our objective here is to derive the insights needed to
determine the feasibility and applicability of inhibiting the action of the mitotic kinase citron kinase (CIT) as novel
CaP treatment. We hypothesize that the mechanism(s) by which CIT, and its kinase activity, control CaP cell
proliferation can be exploited as alternative CaP treatment to overcome acquired resistance to conventional CaP
therapies. This hypothesis is formulated based on preliminary work produced in our laboratory, which identified
CIT and its kinase activity as a novel critical determinant of CaP growth. The rationale is that this work may lay
the foundation of a much-needed novel CaP therapeutic that targets specifically CaP growth during disease
progression. We will test this hypothesis by pursuing 3 Specific Aims: 1) to define the mechanism(s) that control
CIT protein expression, 2) to determine the manner in which CIT conveys aggressive CaP behavior, and 3) to
determine the therapeutic potential of targeting CIT during CaP progression. Aim 1 will use molecular biology
and cell biology approaches to delineate the molecular mechanism by which the novel E2F2-Skp2 signaling axis
induces CIT protein levels, and specifically the role of Skp2-mediated degradation of p27 herein. In Aim 2, we
will define the manner in which CIT conveys aggressive CaP behavior by isolating the CIT protein interactome
and CIT kinase substrates that mediate CaP cell proliferation. Integrated kinase substrate assays and proximity
ligation assays coupled with mass spectrometry will be performed. Aim 3 will define the therapeutic potential of
genetic or pharmacological CIT inhibition on the growth of CaP cell line xenografts, PDXs and fresh patient tissue
explants before and after ADT, and compare its efficacy to that achieved by the standard of care. The proposed
research is innovative because it focuses on an entirely different approach to CaP treatment: targeting the
action of a novel regulator of CaP growth to inhibit progression of advanced CaP and to bypass CaP treatment
resistance. This contribution is significant because it is the first step in a continuum of research that is expected
to lead to the development of novel treatment modalities that target specifically the molecular mechanisms that
control lethal CaP progression. With respect to expected outcomes, the proposed studies will delineate how
CIT controls CaP cell proliferation and establish its value as much-needed therapeutic target during CaP
progression. These results will have a significant positive impact because they will fundamentally advance
knowledge of the mechanisms that control CaP growth, in general, and provide CIT as an entirely new and
functionally distinct target for much-needed novel Cap treatments, specifically.

Public health relevance
Project Narrative The proposed research is relevant to public health because insights into the specific molecular mechanisms that control prostate cancer (CaP) progression are ultimately expected to provide the foundation to develop novel treatment options that are tailored to the events that underlie the lethal phenotype of CaP, a malignancy that causes more than 30,000 deaths annually in the US. Thus, the proposed research is relevant to the part of NIH's mission that pertains to developing fundamental knowledge that will help reduce the burdens of human cancer.